Role of Fc Receptor in atherosclerotic plaque progression

DESCRIPTION (provided by applicant): Cardiovascular disease is the major cause of death in the United States with most of the morbidity and mortality resulting from plaque rupture. Strokes account for approximately 157,000 of those deaths each year. As the majority of strokes result from plaque rupture, elucidating the differences between vulnerable and stable plaques will aid in the design of therapies to stabilize vulnerable plaques. To this end, we have compared the expression of 21 genes in stable (femoral) and unstable (carotid) plaques obtained from endarterectomy. Not surprisingly, genes involved in the breakdown of the extracellular matrix were elevated in the unstable plaques. Interestingly, components of the Fcγ receptor signaling pathway, including FcγRI, FcγRlla, and FcγRIII are dramatically higher in unstable compared to stable plaques. In vitro studies using human macrophages incubated with immune complexes or C reactive protein (to ligate FcγR receptors) recapitulated the expression profile of the unstable plaque tissue. These data suggest that the FcγR- mediated signaling network is upregulated in unstable plaques and may contribute to plaque progression and/or instability. If true, treatments to decrease FcγR signaling may provide a novel approach for stabilizing vulnerable plaques. However, the role of FcγR in plaque progression and vulnerability has yet to be determined. That is the subject of this application. Three specific aims will test the hypothesis that FcγR contribute to the vulnerability and/or development of carotid plaques. Aim I) Plaque stability in Apo E -/- mice expressing none or all of the activating FcγR will be quantified using 6 standard measures of plaque vulnerability, including lipid accumulation, intraplaque hemorrhage, plaque rupture, and thin cap fibroatheroma, Aim II) the effect of FcγR expression on gene expression profiles will be determined and compared to those of stable and unstable human plaques, and Aim III) the effect of FcγR expression on plaque development will be followed longitudinally using non-invasive, small animal ultrasound biomicroscopy. Completion of these studies will resolve the question of the involvement of FcγR in plaque progression and/or vulnerability and establish the validity of the model as representative of human carotid plaque pathology. The results will provide the rationale for subsequent studies identifying FcγR induced plaque instability genes and assessing the effects of downregulating such genes on carotid plaque progression and vulnerability. Project Narrative: In the United State, 3 people die from heart disease every minute with plaque rupture contributing to the majority of those deaths. Our data suggest that FcR signaling in involved in the development of unstable plaques. This research will determine the role of FcγR in plaque progression and rupture and provide novel targets for reducing heart attack and stroke.